Pregnant Female Reproductive Tissue Mapping Center Data Analysis Core

SUMMARY
The Data Analysis Core (DAC) of the HuBMAP Pregnant Female Reproductive Tissue Mapping Center (PFR
TMC) will perform analysis of each data type generated by the Organ Specific Project (OSP), as well as
integrative analysis of multiple data types aimed at building 3D multiscale tissue maps of the developing and
term pregnant placenta, and term uterine endomyometrium and fallopian tubes; exploration of extracellular RNA-
mediated signaling between the placental and maternal tissues; and tracking of cellular differentiation and
migration in the developing placenta across gestation. These integrative analyses will be facilitated by two
strategies: 1) collection of bridging datasets (datasets that link two data types, such as the 10x Multi-ome assay,
which collects snRNAseq/snATACseq indexed to the same nuclei, or GeoMX DSP WTA, in which the operator
uses tissue morphology and immunohistochemistry to select features for spatial transcriptomic profiling, thus
linking morphology and/or protein expression with transcript abundance); and 2) combining broad surveys of
small numbers of samples for many samples with deep spatial profiling of multiple serial sections from selected
exemplar tissue blocks to build detailed models of tissue architecture. The DAC will collaborate with the HuBMAP
Integration, Visualization & Engagement Collaboratory (HIVE) to build an atlas of 3D tissue maps in the context
of the whole human body. The DAC is responsible for data processing, annotation, metadata curation, analysis,
and map construction within the PFR TMC. The DAC interacts closely with the OSP and coordinates interactions
with the other HuBMAP TMCs, HIVE and NIH Program staff. The DAC ensures that data, metadata, software
and tools will be open, findable, accessible, interoperable, reusable (FAIR) and maintains flexibility to adapt
processing and analysis capabilities to emerging technologies within the HuBMAP Consortium. The DAC has
assembled a PFR TMC Data Release Team comprised of experts in each of the included data modalities that
interfaces directly with the HIVE to ensure data quality control, metadata standards and facilitate data transfer.
The DAC collaborates closely with the HIVE to optimize secondary analysis pipelines and to implement the
Registration User Interface to register tissue sections to reference organs and a Common Coordinate Framework
to fully integrate spatial and molecular data across individuals. Since the establishment of the PFR TMC 15
months ago, the DAC has been involved in development of Consortium-wide metadata standards, data quality
metrics, analysis techniques and data structures, particular in the areas touching upon the specific data and
tissue types utilized by the PFR TMC.